The role of a Coxiella burnetii effector protein that inhibits RIG-I signaling

Project Summary/Abstract
Coxiella burnetii is an obligate intracellular bacterial pathogen that grows within a lysosome-derived vacuole.
The formation of a replication-permissive vacuole by C. burnetii requires a type IVB secretion system called
Dot/Icm, and the >130 effector proteins delivered by this system into the host cell. While it is established that
the collective activities of these effector proteins remodel host signaling networks to create a replication-
permissive environment, the molecular targets and biochemical mechanisms of most of these effectors are not
known. My studies have established that C. burnetii inhibits the activation of the host RIG-I pathway, a
cytosolic double-stranded RNA sensing pathway, and that this process requires two effectors, EmcA and
EmcB. Although these proteins do not have predicted sequence or structural homology that would indicate
possible biochemical functions, we established that EmcB has cysteine deubiquitinase activity. EmcB directly
targets RIG-I and preferentially cleaves long, K63-linked ubiquitin chains that are potent activators of RIG-I
signaling. The goal of this study is to determine how EmcB functions to cleave ubiquitin chains from RIG-I
during infection and identify how C. burnetii infection is sensed by RIG-I. To achieve this goal, I will use
biochemical assays, pull-down experiments, and infection studies using a newly engineered emcA, emcB
double mutant to determine how EmcB functions to inhibit the RIG-I pathway during infection (Aim 1). Next, I
will identify the specific RNAs sensed by RIG-I during C. burnetii infection and test the relative capacity of
these RNAs to activate the RIG-I pathway (Aim 2). Together, these studies will enhance our understanding of
how intracellular bacterial pathogens modulate host signaling networks for productive infection. By
understanding the molecular details of how an intracellular pathogen modulates host processes, fundamental
details of C. burnetii infection will be uncovered which could provide insights that lead to improved treatments.
These studies will be complemented by a rigorous and comprehensive program of professional training, clinical
training, and scientific skill building to provide preparations necessary to pursue a career as a physician-
scientist investigating molecular mechanisms of microbial pathogenesis.

Public health relevance
Project Narrative Intracellular bacterial pathogens remodel mammalian cell processes to replicate and cause disease. We propose to investigate how the intracellular pathogen Coxiella burnetii modulates the immune response to infection. This study will uncover fundamental details of the requirements for intracellular replication by bacterial pathogens and provide a possible therapeutic target for the treatment of these infections.